Visual Network Connectivity and Perceptual Modulation in Early Psychosis

Abstract
Psychosis is a debilitating chronic illness associated with marked impairments of functional capacity in individuals
and a significant economic burden for society. Despite various treatment options to address the positive
symptoms of the illness, relatively few have been successfully developed to target cognitive symptoms that
account for significant deficits in social and occupational functioning. Recent work suggests that deficits in
bottom-up visual perceptual processes contribute to these more established cognitive impairments and their
associated functional decline. Furthermore, distortions in visual perception have a significant clinical impact,
particularly during early stages of the illness, despite being underappreciated in traditional clinical settings.
Unfortunately, our limited understanding of the relationship between perceptual and cognitive systems in
psychosis hinders our ability to isolate targets for therapeutic interventions. The proposed study will examine
disruptions in bottom-up perceptual responses emerging from local cortical processes in addition to their
modulation by coordinated activity across a distributed attentional network and ascertain the impact of each on
clinical outcomes in first-episode psychosis. Response amplification in visual contrast perception, a well-
documented disruption in chronic psychosis with implications for treatment of the disorder, remains understudied
at disease onset. Moreover, the top-down modulation of this fundamental perceptual mechanism remains
unexplored in psychotic illness despite significant literature detailing the facilitation of contrast perception via
attention in healthy populations. I hypothesize that this modulation, mediated by long-range cortical
communication across a distributed visual attention network, will exhibit marked disruption and be more closely
associated with cognitive and functional deficits in early psychosis compared to disruptions in local perceptual
responses. I will use simultaneously recorded M/EEG data to localize regions of visual cortex exhibiting altered
stimulus contrast processing. This approach will also be used to isolate sources of impaired connectivity across
regions of the dorsal attention network underlying the modulation of contrast perception by attention in healthy
adults. Finally, symptoms and functional impairments will be assessed using validated clinical instruments to
quantify the clinical impact of these visual processing deficits in first-episode patients. Identifying the various
levels of information processing at which dysfunctions arise in psychosis is key to elucidating the mechanisms
underlying its least well treated yet most devastating symptoms. Results from this study will inform interventional
approaches targeting specific disruptions in visual processing associated with negative clinical outcomes.
Examining disruptions at an early illness stage will help disambiguate the effects of primary disease processes
from confounds such as age and medication usage and inform longitudinal trajectories of these disease
impairments to identify vulnerable developmental timepoints and maximize the benefits of our interventions.

Public health relevance
Project Narrative Disturbances in visual perception are highly prevalent in psychotic disorders and deficits in the processing of stimulus contrast have been linked to cognitive deficits and functional decline in chronic schizophrenia. The integrity of this mechanism, however, remains understudied at disease onset and our understanding of its modulation by coordinated yet broadly distributed cognitive systems in psychosis is lacking, limiting our attempts to target primary sources of disease morbidity. This project will examine the neural basis of visual perceptual modulation and its association with clinical impairment at first-episode psychosis to inform targeted treatment approaches.